Organizational/Resource Assess:Treatment Providers (RMI)

[unreadable] DESCRIPTION (provided by applicant): The proposed supplement extends a cost analysis workbook used in the parent grant beyond data entry to include a computerized cost-analyst interview and an Internet-based prototype. The specific aims are to advance the research of the parent grant by bringing together a multidisciplinary team of researchers from two universities to develop a new computer interview methodology for collecting cost data, test this new approach against a paper-and-pencil instrument used in research applications, assess the likelihood of adoption by community-based providers, and develop an Internet-based prototype that can be tested and used in future research. In general, existing research methods and forms for cost data collection have not found their way into routine community-based practices, outside of research applications. Further development of practical, easy-to-use methods that enable providers to conduct their own economic evaluations of cost will enhance diffusion efforts. Moreover, making such methodologies readily available will also help to promote their use and transfer into routine practice. This application is responsive to at least two of the four areas identified in the RFA (i.e., measurement and data collection techniques). Methods, measures, and instruments will be refined to bridge a gap between research and practice. The emphasis is on simplifying and automating economic data collection through a more functional and interactive interview, leading to a prototype of a web-based costing tool. This prototype will be the focus of future research, with a potential to allow for dynamic, up-to-date feedback through report generators, as well as real-time data runs for the production of aggregate cost comparisons and cost benchmarks for outpatient treatment services. Such feedback could be used to set appropriate charge rates, forecast funding needs, negotiate managed care contracts, and facilitate optimal use of scarce resources. Indeed, this technology is being developed for substance abuse treatment providers; however, it is applicable to other health service settings. [unreadable] [unreadable]